Restoring complex movement and locomotion after paralysis through collaborative copilots

PROJECT SUMMARY
There are no widespread devices available that signiﬁcantly improve the quality of life for those with paralysis.
A widespread and effective device for paralysis should be low risk, yet high performance, enabling complex
movements needed to perform everyday tasks. We propose to achieve a low risk, high performance device
through three thrusts. Our ﬁrst thrust is to capitalize on advances in artiﬁcial intelligence (AI) that enable us to
train robots that perform the same types of tasks that humans perform, including folding laundry, putting food in
a pan, opening door knobs, or picking up a bag of chips. Because robots can perform these tasks, we reason
that as long as an AI copilot can infer a human's goal to perform a certain movement, the copilot can then help
perform the complex movements associated with the task. We achieve this by training new copilot architectures
that use computer vision, as well as non-invasive signals reﬂecting the user's intent, to perform complex actions.
Our second thrust is to take advantage of and fuse many non-invasive signal sources, which together provide
enough information for the copilot to infer the user's goal and help the user complete an action. Our third thrust
is to develop methods to adapt the user and copilot as they share control. We hypothesize this will have a key
impact on increasing system performance and robustness. We believe this proposed work, if successful, will
have a transformative impact on the development of clinically viable devices that help people with paralysis move
autonomously.

Public health relevance
PROJECT NARRATIVE We aim to build non-invasive assistive devices to help people with paralysis perform complex and everyday activities. We record from multiple non-invasive signal sources to decode user intentions, and we train advanced artiﬁcial intelligence copilots to help the user complete these goals seamlessly.